Human Coronary Artery Plaque Transcriptomes and Cardiovascular Risk Assessment

Atherosclerotic coronary artery disease remains a leading cause of morbidity and mortality worldwide. While
significant advancements have been made in understanding the pathogenesis of atherosclerosis through
animal models and atherosclerotic plaques from non-coronary arterial beds, crucial knowledge gaps still exist
regarding human coronary atherosclerosis and the ability to predict plaque stability. Using a novel approach
designed by our research team, this NIH R01 proposal aims to begin addressing these limitations by analyzing
the transcriptome of human coronary atherosclerotic plaques (HCPs) from patients undergoing percutaneous
coronary interventions and investigating their role in predicting subsequent myocardial infarction and other
major adverse cardiovascular events (MACE) following percutaneous coronary interventions (PCI).
In Aim 1, we will determine differences in the composition, molecular functions, and biological processes of
HCP transcriptomes between plaques from patients with acute coronary syndromes (ACS) and stable coronary
artery disease (CAD), as well as between men and women. This aim will involve sequencing the
transcriptomes of HCPs obtained from 2,400 patients undergoing PCI across three centers with diverse racial
and ethnic backgrounds. Additionally, differences between ST-elevation myocardial infarction (STEMI) and
non-ST-elevation myocardial infarction (NSTEMI) presentations will be explored.
In Aim 2, we will evaluate the predictive value of HCP transcriptome data for future MACE. This aim involves a
comprehensive follow-up of all subjects for 36 months post-PCI, during which MACE events, including
subsequent ACS, recurrent unplanned revascularization, and death, will be recorded. The transcriptomes of
patients with and without MACE will be compared to identify transcriptome patterns with potential prognostic
implications.
Our exciting preliminary data from a pilot study involving 27 patients demonstrates the feasibility of obtaining
HCP transcriptomes. A solid infrastructure has been established, enabling subject recruitment, sample
collection, and long-term follow-up for over 250 patients to date. The pilot study also highlights significant
differences in gene expression, regulatory pathways, and cell populations between unstable plaques
associated with ACS and stable plaques in patients with stable angina. Importantly, our preliminary data also
suggests there are significant differences in gene expression in coronary plaques in men compared to women
and comparing those who had ACS following their index procedure compared to those who did not.
Successful completion of this study will contribute to a deeper understanding of human coronary
atherosclerosis, elucidate critical biological differences between ACS and non-ACS plaques, and identify
potential therapeutic targets. Furthermore, our findings may establish a first-of-its-kind tool for risk stratification
of MACE post-PCI, enhancing patient care and prognosis prediction.

Public health relevance
Our current understanding of how blockages in human coronary arteries become unstable is incomplete, and our ability to predict future heart attacks in patients who have had blockages treated with stents and balloons is limited. We have developed a novel way to determine the genes expressed in human coronary plaques by obtaining the genetic material from balloons used when blockages are opened. These data will provide a deeper understanding of human coronary atherosclerosis, show important biological differences between stable and unstable plaques, identify potential therapeutic targets, and establish a new tool to predict the future risk of heart attacks in patients.